Genome engineering for a novel post-reproductive genetic screen for increased longevity

Project Summary
The discovery of the first mutations known to increase longevity a little more than thirty years ago revolutionized
the field of aging research. Despite their fundamental importance, it has been notoriously difficult to screen for
pro-longevity mutations directly because by definition the effects of the mutation cannot be known until late in
life, and very old animals tend to not be able to reproduce. Crosses between individuals have long been
fundamental to genetics, both because that is what is needed to map and identify a given mutation and also
because reproduction is key to propagating the mutation after it is initially found. There are strategies such as
family selection to compensate for this, but they tend to be highly laborious and low throughput. Here, we propose
to build upon a comprehensive genetic library transgenesis approach that we have created called “Transgenic
Arrays Resulting In Diversity of Integrated Sequences” (TARDIS) to create a Cas9 RNA guide system that will
allow comprehensive whole genome targeted mutagenesis in an animal model for the first time. TARDIS
provides the benefits of library-based transgenesis that is frequently used in microbial species, but capitalizes
upon the ability of the model nematode Caenorhabditis elegans to produce and propagate extra chromosomal
arrays. Elements of the array are pulled at random into a single landing pad site in the genome, constructed so
as generate a selectable marker upon guide integration. This system has the advantage of allowing the entire
genome to be targeted using a curated synthetic library in a defined and reproducible manner. But more
importantly for longevity screens, because the guide is found at a well-defined location in the genome, the
resulting mutation can be identified via simple sequencing of a single site in a single individual. Reproduction is
therefore not necessary to map or propagate the mutation. This system therefore provides an approach for the
first fully comprehensive screen of pro-longevity mutations in an animal model. Specifically, we aim to (1) develop
this new library based mutagenesis system within C. elegans, and (2) use this system to screen for novel
mutations that increase individual longevity. Mutations identified in this fashion will be confirmed via
recapitulating the same genetic change in a standardized line via CRISPR genome editing, allowing for a
comprehensive analysis of the mutations effects on longevity. This project will create a wholly new approach for
screening for mutations for any post-reproductive phenotype, as well as any mutation that precludes reproduction
per se. It will also produce a new set of genetic lines containing pro-longevity mutations. Both of these outcomes
should be of broad benefit to the genetics and aging research community.

Public health relevance
PROJECT NARRATIVE Aging is the number one risk factor associated with disease in the United States. Although we take this granted, genetic discoveries over the last few decades suggest that it is possible to directly intervene on the aging process itself, to date it has been very difficult to look for new mutations affecting aging and longevity because individuals at extreme old age tend to be past the ability to reproduce, even in model organisms. This work aims to expand new genome editing technology to rapidly produce and identify mutations that enhance longevity in post-reproductive individuals, setting the stage for future development of drugs and other interventions aimed at extending health aging in all people.